VACMAN: A COMPUTER PROGRAM FOR ANALYZING VIRAL TREATMENT TRIALS IN PRIMATES

Reports on HIV treatment trials in primates rarely publish any statistical analysis. VacMan is user-friendly computer program intended for a virologist's use on Macintosh, IBM Windows, and SUN X-Windows. VacMan's windowing interface was made possible by the NCBI Coretools and Vibrant software packages. VacMan calculates statistics for in vivo and in vitro infectivity data. The VacMan's statistical techniques are based on Bayesian analysis, but have a novel means of statistical inference: Bayesian predictive distributions are used like classical direct probabilities to make decisions about null hypotheses. The resulting decisions agree remarkably well with virologists' opinions about primate trials, but are objective and quantitative. Quantitative assessment of primate trials leads to several unappreciated principles of effective animal use: dilutions other than 10-fold can improve titration accuracy; infecting titration animals at the lowest doses possible can lower challenge doses; and finally, challenging test animals in small trials with more virus than controls safeguards against false successes, "reuses" animals, and strengthens experimental conclusions. These principles take on greater significance when one considers that chimpanzees in HIV trials cost about $50,000 each to use, and are an endangered species.